P30 Administrative Supplement for Assessing and Enhancing Survivorship Care

PROJECT ABSTRACT
The complexity of childhood cancer survivorship care delivery necessitates systematic
optimization, especially as the U.S. survivor population approaches 580,000. The St. Jude
Comprehensive Cancer Center's Cancer Control and Survivorship Program aims to enhance care
through multidisciplinary approaches, yet significant barriers persist, particularly in non-
specialized clinics. Existing guidelines require detailed cancer histories and treatment risk factors,
challenging to obtain in community settings where providers often manage few, diverse survivors.
Currently, most survivorship follow-up care is provided by primary care providers who often lack
the necessary expertise and resources. Different models of survivorship care have been
developed to aid in this process, such as community-based shared-care and comprehensive
survivor programs. However, these continue to face unique challenges and have not proven
universally effective. Qualitative interviews about survivorship care have begun to identify
important barriers and highlight healthcare systems challenges survivors and providers face when
attempting to deliver effective care to survivors. This study seeks to address gaps in survivorship
care delivery by employing system dynamics and group model building to explore barriers and
interconnections within the care process. The proposal will generate a qualitative model of
survivorship care developed in collaboration with patients, families, and clinicians involved in their
care. This involves two primary aims. We will conduct sequential group model building workshops
with clinical teams (Aim 1) as well as survivors and their families (Aim 2). This work will result in
the development of causal loop diagrams to describe the complex system of care and will be used
to identify leverage points. Participants include primary care providers, subspecialists, oncology
teams, and survivors/families. This research is significant for its potential to elucidate the
complexities of survivorship care, enhancing accessibility and equity beyond highly resourced
settings. The innovative participatory modeling approach will generate qualitative models
considering multimorbidity, health-related quality of life, psychosocial adversity, geographic
constraints, and genetic predisposition. This comprehensive model will guide the design,
dissemination, and implementation of effective survivorship care solutions, ensuring sustainable
and high-quality care delivery for childhood cancer survivors across diverse settings. The insights
gained will contribute to better health outcomes and quality of life for the growing population of
pediatric cancer survivors.

Public health relevance
PROJECT NARRATIVE This project aims to utilize group model building with clinicians, patients, and families to develop the first qualitative model of childhood cancer survivorship care. The model will identify and analyze barriers within the care process to improve accessibility and adherence to guidelines in non-specialized clinics. The outcomes will identify optimal targets for improving survivorship care, thereby enhancing health equity and improving care delivery for the growing survivor population.